SAFETY AND FEASIBILITY OF CONTINUOUS CEREBROSPINAL FLUID SAMPLING

The purpose of this study is to obtain pilot data on the safety and feasibility of continuous cerebrospinal fluid (CSF) sampling via an indwelling lumbar catheter for a period of 30 hours.